Deciphering genotype-environmental interaction that drives HSPC dysfunction

1 PROJECT SUMMARY
2
3 Hematopoietic stem and progenitor cells (HSPCs) are long-lived immature cells that retain the potential to
4 generate all blood cell lineages including erythroid, myeloid, and lymphoid. HSPC dysregulation is a major driver
5 of myeloid malignancies including myelodysplastic syndromes (MDS). This disorder is a significant health
6 problem with approximately 10,000 people per year diagnosed with MDS in the United States. The ATPase
7 DEAD-box Helicase 41 (DDX41) gene is mutated in an inherited form of adult-onset MDS, providing a compelling
8 model to investigate the mechanism of MDS progression. These mutations are heterozygous and loss-of-
9 function, indicating that diminished DDX41 levels contribute to MDS etiology. Individuals with DDX41 mutations
10 take years to develop MDS, suggesting that features of aging contribute to the asymptomatic-to-smoldering
11 malignancy transition. Human and zebrafish DDX41 are highly conserved. Like humans, ddx41 heterozygous
12 zebrafish begin to display altered hematopoietic features such as elevated HSPC frequency, shifts in myeloid
13 cell composition, and dysplasia. These findings implicate aspects of aging contribute to disease evolution in our
14 model similar to humans. I hypothesize that environmental alterations synergize with genotype-specific factors
15 to promote HSPC dysfunction. Previously, we showed that HSPC expansion in homozygous ddx41 zebrafish
16 mutants during embryogenesis was driven by cGAS-STING activation. This pathway is associated with age-
17 driven inflammation; thus, we will test the hypothesis that aging and cGAS-STING activation could play a role in
18 age-associated HSPC expansion in ddx41 heterozygous animals. Neutrophils are also key regulators of HSPC
19 function. Aging and mutations in MDS-associated factors are linked with neutrophil dysfunction. We will test the
20 model that ddx41 heterozygosity alters neutrophil functions and that this dysfunction contributes to age
21 associated HSPC expansion. My findings have the potential to uncover new ways to prevent MDS progression
22 and will also provide valuable insight into fundamental mechanisms controlling HSPC homeostasis.

Public health relevance
PROJECT NARRATIVE Malfunctioning of hematopoietic stem and progenitor cells (HSPCs) is a major driver of myelodysplastic syndromes (MDS). Individuals carrying a DDX41 germline mutation develop MDS later in life, suggesting aging features play a key role in promoting disease. Our study will identify which aspect of aging promotes progressive HSPC dysfunction.